Non-surgical treatment option for pelvic organ prolapse

Project Summary / Abstract
Reia is working to address a prevalent gynecological condition, pelvic organ prolapse (POP), which
affects more than 50% of women over the age of 50. POP occurs when the pelvic floor connective
tissue and muscles weaken, allowing the uterus or vaginal walls to descend. In extreme cases, the
uterus descends through the opening of the vagina and hangs outside of the body. POP can be treated
non-surgically with a pessary that is inserted into the vagina and acts as a shelf to support the
descending organs. Commonly used pessaries have a fixed and rigid design, making them difficult or
impossible for patients to remove and insert independently. Reia has developed an innovative
collapsible pessary to reduce pain and discomfort associated with pessary insertion and removal.
During Phase II, the pessary successfully passed all FDA required mechanical, microbiological, and
biocompatibility tests. Reia has evaluated its pessary in n=50 current pessary users between its early
feasibility and feasibility trials. Subjects reported increased comfort during insertion and removal when
using Reia’s pessary compared to their current pessaries and their prolapse was effectively supported.
During Phase IIB, Reia will (1) prepare and submit a 510(k) clearance application to the FDA. Reia will
achieve this aim by professionally manufacturing and testing fitting pessaries, performing packaging,
shipping, and distribution testing, and compiling the 510(k) application. Reia will (2) modify and optimize
a pessary applicator, which was designed during Phase II to increase access to self-management. To
achieve this aim, Reia will professionally manufacture a ß-prototype with medical grade materials,
perform benchtop mechanical, biocompatibility, and cleaning validation testing, and assemble a 510(k)
application. Reia will (3) conduct a clinical trial comparing success of home-management between
Reia’s pessary system (pessary and applicator) and the standard of care in pessary-naïve patients.
Defined evaluation criteria have been established to measure progress and success.
Reia’s founding team is comprised of a urogynecologist with 25 years of experience fitting pessaries
and treating POP and a 3-person, female executive management team with combined experience in
product development, operational manufacturing and production practices, and IP advisory.
Additionally, an advisory board contributes expertise in urogynecology, commercialization of medical
devices, and successful completion of numerous NIH grant funded projects. Reia has strategically
aligned with manufacturing facilities, testing laboratories, and regulatory consultants to gain access to
necessary equipment, resources, and guidance to successfully complete this project.
Reia is committed to optimizing its pessary system for clinical use and manufacture to bring to market
the first-ever pessary specifically designed to address women’s needs.

Public health relevance
Project Narrative The purpose of this proposal is to optimize and prepare to commercialize a novel, collapsible vaginal pessary and applicator for the non-surgical treatment of pelvic organ prolapse (POP), a condition that symptomatically affects 3.7 million women in the United States. Recent medical studies suggest that surgical treatments for POP are less effective than once believed, and current pessaries in common use are limited by a rigid and fixed design, which can make them uncomfortable as well as difficult or impossible for patients to remove and insert independently. Consequently, there is an imperative to develop non- surgical treatment alternatives for women who suffer with POP which are easy to use, accepted, effective, comfortable, and cause minimal complications.